Project 5: Targeting Oxidative Phosphorylation in AML

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) comprises a genetically and clinically heterogeneous group of
aggressive hematological malignancies. Despite advances in molecular characterization of AML, the
majority of patients will relapse and die of their disease. In AML, oxidative phosphorylation (OxPhos)
generates intracellular energy and metabolic intermediates necessary to promote growth and support
survival. Unlike normal hematopoietic stem cells, AML and leukemia stem cells (LCS) overexpress anti-
apoptotic mitochondrial protein Bcl-2, rely on OxPhos and are unable to utilize glycolysis when
mitochondrial respiration is inhibited, indicating that the maintenance of mitochondrial function is
essential for AML survival.
We have identified a novel potent nanomolar inhibitor of OxPhos (OxPhosi) IACS-010759,
selected from the series of more than 1,000 compounds across distinct structural classes. IACS-010759
has been found to inhibit complex I of OxPhos respiratory chain and block oxygen consumption. Our data
demonstrated profound growth-inhibitory and pro-apoptotic effects of this agent in AML cell lines and
primary AML cells at low nM concentrations, with minimal toxicity against normal BM cells. In turn,
combination of OxPhos inhibitors and Bcl-2 inhibitor venetoclax is synergistic in AML. Daily dosing of
IACS-010759 was well tolerated in mice, demonstrated strong efficacy in the in vivo xenograft studies
utilizing the human AML patient-derived xenografts (PDX) and reduced phenotypically defined LSC
fractions measured by novel technique of mass cytometry, CyTOF. Administration of OxPhosi following
standard chemotherapy extended survival in primary AML PDX model. A Phase I clinical trial of IACS-
010759 in relapsed/refractory AML was recently launched at MDACC.
We propose to test the hypothesis that OxPhos inhibition constitutes a novel therapeutic
approach that targets a unique metabolic vulnerability of AML; and that combined blockade of
mitochondrial respiration by OxPhos and Bcl-2 inhibitors will eliminate leukemia-initiating cells and
produce objective responses. We will establish biomarkers of response to OxPhosi in vitro including RNA
and metabolomics signatures, in a large series of primary AML with known genetic profiling, and validate
these in the in vivo AML PDX models. We will further determine mechanisms of synergistic AML cell
death when OxPhos inhibition is primed by Bcl-2 blockade with venetoclax, and characterize anti-AML
and anti-LSC efficacy of such combination. We will further metabolically profile AML cells surviving
standard chemotherapy, and test the hypothesis that OxPhosi will reduce or eliminate residual surviving
AML cells. These concepts will be translated into Phase 1/2 study of standard chemotherapy and of Bcl-
2 inhibitor Venetoclax combined with IACS-010759 in patients with relapsed/refractory AML.

Public health relevance
PROJECT NARRATIVE A leukemia called AML cannot be cured by current treatments in more than half of adult patients. This project will test novel experimental drug affecting tumor metabolism, alone and in combinations, for suppression of AML disease development in laboratory models. Phase I/II clinical trial will examine safety and efficacy of combinations with standard chemotherapy or with targeted therapies in relapsed/refractory AML.